Genes, the Environment, and Me: Health and STEM Network (GEMNET)

PROJECT SUMMARY Through Genes, the Environment, and Me: Health and STEM Network (GEMNet), we will develop a model for teaching about type 2 diabetes (t2d) and engaging students in biomedical careers using a cross-disciplinary approach with high school biology, health, and Family and Consumer Science (FACS) teachers. Diabetes is a complex condition that unites science and health concepts, and links these concepts to broader social issues, i.e., environmental influences, health care, scientific research, personal choice, access to resources, diet and exercise, social justice, and public policy. The nature of this complex topic lends itself to multi-disciplinary instruction in which students can benefit from exposure to different aspects of t2d in different high school contexts. This project builds on our successful SEPA-funded project, Genes, the Environment, and Me (GEM). Through GEM, we have developed a strong community of high school science and health teachers primarily in the Yakima Valley, a rural agricultural region in central Washington. Schools in this region serve highly diverse students with high percentages of Hispanic and Native American students, many of whom are from high poverty families with limited English proficiency and low educational attainment levels. These are also populations that experience disproportionately high rates of t2d, which makes this a timely and important topic to integrate into high school curricula. We will build upon our established community of high school teachers in science and health in central Washington and expand our network and curriculum to other communities and disciplines, including teachers in the Seattle School District. GEMNet will produce standards-based curriculum to teach about t2d and related health issues for inclusion in introductory and advanced high school biology, health, and FACS courses. Project components will include: 1) developing and piloting new t2d lessons specific to the different high school courses; 2) providing discipline-specific teacher professional development; 3) evaluating student outcomes following one or more exposures to the curriculum in different classes; and 4) disseminating instructional materials and strategies within our primary teaching community and to other regions of the state and nation.

Public health relevance
NARRATIVE Through Genes, the Environment, and Me: Health and STEM Network (GEMNet), we will develop, implement, and evaluate a cross-disciplinary model for teaching about type 2 diabetes (t2d) in high school biology, health, and Family and Consumer Science classes, and promoting interest in biomedical and science careers. We will work with schools in Seattle, the Yakima Valley, and other rural regions of Washington State. Project evaluation will focus on measuring the impacts of the curriculum and delivery model on students' knowledge about t2d, perceptions of self-efficacy in preventing t2d, and interest in STEM careers in their community.